Role of Central Amygdala Somatostatin in Heavy Alcohol Drinking

ABSTRACT
A characteristic symptom of alcohol use disorder (AUD) is “hyperkatifeia,” a hypersensitivity to emotional distress,
which is thought to be caused by specific neuroadaptations in the extended amygdala. Specifically in the central nucleus of
the amygdala (CeA), the recruitment of pro-stress neurotransmitter systems results in the establishment of negative
reinforcement and in excessive alcohol drinking, while, concurrently, the activation of anti-stress neurotransmitter systems
attempts to buffer the aversive states brought about by the excess activation of pro-stress systems. Somatostatin (SST) is a
polypeptide highly expressed in the CeA, region highly implicated in alcohol drinking and stress. Administration of either
SST or SST receptor 2 (SST2R) agonists in rodents produces anxiolytic- and antidepressant-like effects; stressors increase
SST levels in the brain and SST signaling counteracts various components of the stress response. However, the role of CeA
SST (putatively anti-stress) in AUD is currently unknown. The overall hypothesis of this application is that the activation
of the SST/SST2R system in CeA represents a major brain anti-stress element that buffers the hyperactivity of stress systems
and thereby act as a brake to heavy alcohol drinking. This application will test the hypothesis that the activation of the
SST/SST2R system in CeA reverts the increased GABA transmission induced in CeM neurons by chronic alcohol and
blocks heavy alcohol drinking. Our team will test these hypotheses by using a well-established animal model of heavy
alcohol drinking, combined with pharmacological, molecular, and electrophysiological approaches. If successful, these
experiments will have identified a key brain anti-stress system contributing to alcohol addiction which will be investigated
in greater depth in future studies. A deeper understanding of the molecular mechanisms underlying heavy drinking and the
neuroadaptations occurring in the amygdala neurocircuitry may uncover novel and more effective strategies for treating
AUD.

Public health relevance
PROJECT NARRATIVE Alcohol is the most common addictive substance in the United States. This important project will lead to the identification of the role of a key neuropeptide with anti-stress activity in heavy alcohol drinking and anxiety. A deeper understanding of the neuroadaptations produced by chronic alcohol will be essential for the discovery of therapeutic agents to alleviate alcohol use disorders.